CONFERENCE ON COMPUTERIZED ELECTROCARDIOGRAPHY

Funds are requested to support publication of the proceedings of the 1995 Conference on the Computerized Interpretation of the Electrocardiogram (20th Annual Conference). The topic area is particularly important with the volume of computer-processed electrocardiograms on the order of 54 million in 1987 in the United States and over 15,000 devices in the field with analysis capabilities. The objective of this conference is to exchange information about automated electrocardiologic advances among basic scientists, clinical researchers, biomedical engineers, epidemiologists, computer scientists and electrophysiologists. The majority of participants are from academic organizations, with considerable international participation; research scientists and engineers from industry will also be represented. The multidisciplinary nature of the participants will allow in-depth exploration of scientific/technical issues such as the cellular electro- physiologic basis for ST-T changes, the mechanisms for ventricular fibrillation, new developments for the cellular basis and theoretical modelling of body surface mapping, high-frequency signal-averaged ECGs, new mathematical analyses of cardiac rhythms, latest developments in artifact and noise reduction and signal enhancement. Eight sessions are planned over a 4-day period, including a Young Investigators' session. The philosophy of the ISCE conferences, patterned after the Gordon conferences, is to maximize opportunities for discussions. Formal presentations with considerable time for discussion are held mornings and evenings. Afternoons are available for free discussion in small study groups or workshops and for poster sessions. The scientific areas addressed ideally match the interests of the clinical electrocardiologist, electrophysiologist and bioengineer readership of the Journal of Electrocardiology.